Understanding the role of modifiable lifestyle and psychosocial factors in moderating genetic risk for alcohol use problems in veterans

The current Career Development Award-Level 1 (CDA-1) proposal will expand Dr. Peter Na’s
research scope to incorporate psychiatric genetics skills through comprehensive training in
psychiatric genomics, statistical genetics, functional genomics and advanced psychiatric
epidemiology. His mentors are leading experts in the field of psychiatric genetics and psychosocial
epidemiology - Drs. Joel Gelernter, Robert Pietrzak, and Renato Polimanti, with collaboration from Dr.
Hang Zhou, a computational biologist. Dr. Na will also pursue additional training through advanced
workshops, seminars and courses offered by Yale University and other institutions. The proposed
research project will investigate environmental (e.g., trauma load), psychosocial (e.g., purpose in life),
and lifestyle (e.g., physical exercise) (EPL) factors that moderate polygenic susceptibility for alcohol
use disorder (AUD) in Veterans using state-of-the art polygenic risk scores (PRS) computed from the
world’s largest contemporary genome-wide association studies (GWAS) of this disorder. Further, the
proposed study will advance the field’s understanding of the biopsychosocial etiology of AUD and
alcohol consumption using cutting-edge genetic research methodologies such as gene enrichment
and drug-repositioning analyses. While there have been advances in the understanding of genetics of
AUD and psychosocial risk and protective factors for this disorder, the interaction between biological
and EPL factors in predicting AUD remain poorly understood. To address this gap, the proposed
study aims to identify EPL factors that moderate polygenic liability for AUD in Veterans using multiple
large data sets, including the Million Veteran Program (MVP), the National Health and Resilience in
Veterans Study (NHRVS) and the Yale-Penn Study. This line of research directly addresses the top
priority research areas of the Veterans Health Administration (VHA) and this RFA (i.e., substance use
disorders, precision medicine, diseases with a high healthcare burden in Veterans). The moderating
EPL variables identified in the proposed study will elucidate targets for clinical interventions to prevent
and treat AUD in Veterans and ultimately help guide VA clinical practices. PRS will be derived using
the GWAS of AUD from the MVP cohort (N=267,391), of alcohol dependence from the Psychiatric
Genomics Consortium (N=46,568), of the quantity-frequency trait derived from the Alcohol Use
Disorders Identification Test from the UK Biobank (N=121,604), and of alcohol consumption
(drinks/week) from GSCAN (GWAS & Sequencing Consortium of Alcohol and Nicotine use;
N=537,352). Potential moderating EPL factors will be selected based on previous literature. The
associations between PRS, selected EPL factors, and their interaction in predicting AUD and alcohol
consumption will be examined using binomial and multinomial logistic regression analyses. PRS
enrichment analysis will be conducted to examine the biological processes affected by the interaction.
Further, drug repositioning analysis will be performed to examine the biological mechanisms and
identify candidate medications for AUD that may be further tested in animal and pilot studies. Upon
successful completion of the proposed training and research project by the end of Year 2, Dr. Na will
acquire sufficient expertise and preliminary data that will be used to pursue larger grants and
continued research support, such as the CDA-2. Such training will be instrumental to furthering his
research knowledge and skills as he pursues an independent clinical research career as a VA
psychiatrist.

Public health relevance
This Career Development Award (CDA)-1 proposal will offer comprehensive training in psychiatric genetics for Dr. Peter Na to advance his research skills to become an independent VA researcher. The proposed research project will investigate environmental (e.g., trauma load), psychosocial factors (e.g., purpose in life), and lifestyle (e.g., physical exercise) factors that moderate the genetic liability for alcohol use disorder (AUD) in Veterans using polygenic risk scores derived from large genome- wide association studies (GWAS). Further, the proposed study will advance our understanding of the biopsychosocial etiology of AUD using cutting-edge genetic research methodologies such as gene enrichment and drug-repositioning analyses. The moderating factors identified in the study will elucidate targets for clinical interventions to prevent and treat AUD in Veterans and ultimately help guide VHA clinical practices.